RFA-TS-24-010: Persistent Environmental Toxicants in Veteran CNS Tissue: Identifying Exposures Determining Higher ALS Risk

PROJECT SUMMARY/ABSTRACT
United States veterans have at least twice the risk of developing amyotrophic lateral sclerosis (ALS) as compared
to the civilian population. Nonetheless, the etiological factor(s) underlying the elevated risk of ALS in military
veterans are unknown. In the general population, specific environmental and lifestyle factors are associated with
increased ALS risk. For example, truck drivers, airline pilots and cabin attendants have an increased risk of ALS,
indicating the potential relevance of exhaust fumes and aircrafts as disease-linked environmental exposures.
Together, the noted disparity in ALS rates among veterans strongly suggests that there are also high-risk
exposures selectively experienced by military personnel that are disproportionate to the general population. Over
their years of service, veterans may encounter numerous neurotoxic exposures (e.g., burn pits, engine exhaust,
firing ranges, contaminated military bases). In order to reliably characterize the pollutant exposure level of
veterans, it is important to directly evaluate persistent toxicants in those biological samples capable of storing
such toxicants relevant to disease. Therefore, under Funding Option A, we propose an innovative evaluation
in veteran central nervous system (CNS) tissue of persistent neurotoxicant mixtures emitted by service-linked
exposure sources. Based on the literature and our own preliminary studies, our proposed toxicants of interest
include: metals/nonmetal elements, nanoparticles, dioxins, and polycyclic aromatic hydrocarbons. To identify
their contribution to disease development, we will characterize and/or compare the concentrations and spatial
tissue-subcellular distribution of persistent toxicants detected in the CNS tissue of veterans with ALS to that of
non-neurologic veteran and non-veteran controls. We will statistically assess if any sets of detected toxicants
exert synergistic toxicity. In addition, we will evaluate how gene expression may be spatially associated with
these deposited toxicants (spatially resolved transcriptomics). As a population, veterans are believed to smoke
and suffer more head trauma/concussions than the general population and we will account for such variables in
our analyses. Together, we believe that this study will greatly increase our understanding of environmental
toxicants that accumulate in military personnel over their years of service and potentially contribute to ALS
pathogenesis. Potential impacts include mitigating neurotoxic exposures, and clarifying the underlying ALS
pathophysiology for therapy development.

Public health relevance
PROJECT NARRATIVE / RELEVANCE The proposed research seeks to identify environmental risk factors for amyotrophic lateral sclerosis (ALS) in military veterans and our hypothesis is that the presence, concentration, spatial distribution and/or combination of persistent toxicants (toxic metals/elements, metal and metalloid nanoparticles, dioxins and polycyclic aromatic hydrocarbons) from service-linked exposures will be higher/different in brain tissue from Veterans Affairs (VA) subjects with ALS, as compared to controls without neurodegenerative illness. We also seek to identify mechanisms involved with metal and toxin exposure using a spatial-omics approach that combines single cell RNA sequencing and spatial gene profiling with our metal / NPs profiles. Potential impacts include reducing toxic exposures in veterans and the broader population as a whole, and inspiring new approaches to therapy.